Reproducible Research in Brain Imaging Genetics

Summary
With advances in modern technologies, an enormous amount of high-throughput neuroimaging and
genomics data are available through large-scale public databases such as the Adolescent Brain Cognitive
Development Study (ABCD) project. These expansive "big multi-modal data" repositories have
spurred the rapid growth of brain imaging genomics studies to improve understanding of the
pathophysiological processes and genetic architecture of mental disorders. However, these large-scale
databases also present significant challenges in data management and analysis, given the common
characteristics of large open data including high dimensionality, data inconsistency, and complex
correlation structures. In addition, a wide gap exists between neuroimaging and statistical genomics
researchers, causing extra barriers to reproducible research in brain imaging genomics. While many
training programs provide neuroimaging or genetics data analysis training, very limited (if any) of them
focus on studying the relationship between neuroimaging and genomics underlying mental health.
This proposal outlines a three-week summer workshop designed to equip graduate-level students or
junior researchers with knowledge and skills to conduct reproducible analysis of brain imaging
genomics. The primary focus will be on learning in best practices how to estimate meaningful
associations of genetic variants on brain structure and function, along with their implications for
cognitive functions and broader mental health outcomes. Our proposed workshop will address the
critical need for training on neuroimaging genomics to build a bridge between cognitive neuroscience
and genomics and promote rigorous and robust analyses of large open brain imaging genomics data
with statistical considerations that are specific to large open data . The workshop also aims to promote
diversity with trainees having different social and academic backgrounds and prioritizing the attendance
of underrepresented scholars.
The workshop will feature in-person training with an interdisciplinary faculty team comprising experts
in statistical and machine learning methodology, genomics, and brain imaging research. We expect that
by end of the workshop the trainees will be able to (1) Learn to access and use large, open brain
research databases and understand analytical and statistical considerations specific to large open data;
(2) know the important scientific questions in brain research and learn to design and conduct
neuroimaging-genotype association studies with clinically meaningful phenotypes; and (3) develop best
practices of coding and documentation for reproducible research of brain imaging genomics. All
lectures, codes, and lab exercises will be made available on GitHub and the course website, ensuring the
widespread dissemination of our training program within the broader community.

Public health relevance
Project Narrative Rapidly increasing availability of high-throughput neuroimaging and genomics data through public databases brings great opportunities yet challenges in brain imaging genomics studies. This proposal is for a three-week in-person workshop to train graduate students and junior researchers to improve their understanding of brain genomics research using neuroimaging phenotypes and learn skills to conduct integrative analysis of brain imaging genomics using large open data in a responsible way. We will have face-to-face instructions that compromise lectures, laboratory practice, seminars, roundtable discussions, and mentored group projects to train researchers in the best practices for reproducible analysis of large, open brain data to learn how to estimate meaningful associations of genetic variants on brain structure and function, along with their implications for cognitive functions and broader mental health outcomes.